Cancer Cell Biology

The Cancer Cell Biology (CCB) Program is comprised of 62 members from 23 departments. Since the past funding cycle the research base of the Cancer Cell Biology has nearly doubled from $15,046,494 to $22,406,120 total annual direct research support, of which $3,643,399 is from the NCI. Over this last grant period, there were 558 publications of Cancer Cell Biology Program members, of which 3.9% are intraprogrammatic and 24.2% are inter-programmatic . Members of the Cancer Cell Biology program are nationally recognized experts in a spectrum of disciplines unified by the goal of furthering our understanding of the process of oncogenesis at the cellular and molecular level, In order to develop new strategies for the treatment and prevention of cancer. Program investigators have advanced cancer biology in the areas of deregulated growth, proliferation, and cell death pathways: chromatin remodeling; cancer stem cells; embryonic signaling pathways; and tumor invasion programs. The bench-based research carried out by our program members has led to translational studies and clinical trials using novel, targeted approaches to cancer therapy which may afford significant advantages over currently available therapeutics.

Public health relevance
The mission of the Cancer Cell Biology Program is to bring together scientists studying basic aspects of cancer biology, including mechanisms controlling initial tumor formation, expansion, invasion, metastasis, and maintenance. By working to identify key molecules that regulate various aspects of tumor biology, an important goal of the Program is to help find new or improved approaches to cancer prevention and treatment.